Preclinical Efficacy of Allogeneic and Human Silicified Cancer Vaccines

Summary
Cell silicification creates cellular entities that retain the cell’s innate structure and protein features; have increased
resistance to heat, pressure and dehydration; and imparts novel surface properties. The process of cryo-
silicification eliminates toxic agents and creates non-viable cells that have adsorbent properties and are
biodegradable, enabling in vivo antigen processing. Adsorption of pathogen-associated molecular patterns, such
as monophosphoryl lipid A and CpG oligonucleotide, transforms the silicified cells into pathogen mimetics. These
immunogenic cancer cells function as therapeutic vaccines that activate suppressed antigen presenting dendritic
cells. Unlike previous vaccine technology using irradiated cancer cells, silicified cells do not present immune
suppressive phospholipid on the cell surface and the cells are stable to dehydration, creating shelf-storable
vaccines. Past clinical studies evaluating autologous and allogeneic irradiated tumor cell vaccines demonstrated
safety, but failed to improve clinical outcomes. To overcome low therapeutic efficacy, we propose replacement
of irradiated cancer cells with silicified cancer cells, surface masked with microbial molecules. Preclinical studies
using syngeneic silicified tumor cells achieved high therapeutic efficacy in mouse models of ovarian cancer. Here
we propose to evaluate the efficacy of allogeneic cancer vaccines, which are desirable based on mass production,
low cost, lack of invasive procedures, and shelf-readiness. To further move towards clinical translation of the
vaccine, we will evaluate human immune responses to silicified cancer vaccines using patient samples, human
TLR agonists, and humanized mice. The main objectives are: 1) Determine if silicified non-syngeneic cancer
vaccines are effective in mouse models of ovarian cancer and breast cancer; and 2) Validate in vivo vaccine
efficacy using human cancer and immune cells.

Public health relevance
NARRATIVE Despite evidence that ovarian cancer is immune reactive, with tumor regression occurring in response to immune modulation, no immune therapy has advanced to routine clinical use. Here we propose to use proprietary technology to transform cancer cells into highly immunogenic pathogen mimetics. Validation of the vaccine in humanized mouse models and therapeutic efficacy of allogeneic vaccines will be studied.